Novel Designed Multi-Ligands as Tocolytics for Dysregulated Myometrial Pathways in the Treatment of Preterm Labor

PROJECT SUMMARY ABSTRACT
Preterm birth is a major medical problem resulting in disability and death for very preterm infants. Therapeutic approaches
to manage preterm labor are off-label and ineffective. No tocolytic therapy in use today is satisfactory beyond 48 hours, and
none is FDA approved. Preterm labor more often impacts African American women than their Caucasian counterparts and
is exacerbated by severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2), which leads to preterm birth in COVID-
19 affected pregnancies. Our central hypotheses are that designed multi-ligand (DML) drugs to be generated in this research
that target dysregulated pathways in preterm myometrium will provide a therapeutic benefit in cases of preterm labor while
decreasing fetal exposure to the compounds, and that co-administration of the DML’s ‘constituent single entities’ will
exhibit synergistic tocolysis. In addition to providing a potential synergistic benefit, we expect that our DMLs will be poorly
transported across the placenta due to favorable pharmacokinetic properties of the DMLs, and thus will protect the fetus
from exposure. Decreased placental transfer will improve dose-ranging for clinical benefit to prevent preterm labor. This
research will justify novel DMLs as potential new tocolytics to prevent preterm birth. This proposal will generate novel
DMLs using advanced Medicinal Chemistry techniques and will make extensive use of ex vivo and in vivo experimentation
using both human and mouse tissue. The long term goal of this project is to generate first-in-class tocolytics that will delay
or halt early labor and prevent preterm birth.

Public health relevance
PROJECT NARRATIVE Preterm labor leads to preterm delivery of an underdeveloped fetus in 50% of cases. There are no FDA- approved medications available to prevent preterm delivery. The research planned in this application will employ tissues from pregnant women and mice to explore the therapeutic potential of novel ‘designed multi-ligands’ and combination tocolytics to delay preterm birth. Our research Aims are designed to address myopathic dysregulation of the uterus to advance a ‘designed multi-ligand’ and combination drug strategy to prevent preterm birth.